Georgia Department of Agriculture; Laboratory Support Improvement Plan

Georgia Department of Agriculture - Laboratory Accreditation Project Summary / Abstract The Manufactured Food Regulatory Program Standards (MFRPS) establish a uniform foundation for the design and management of state programs responsible for the regulation of manufactured food facilities, including laboratory analysis for chemical and microbiological contaminants. Based on the Georgia Department of Agriculture 2011 Improvement Plan Report, needs were determined and established for the cooperative agreement application funding which include: Fund and fill staff vacancies associated with key quality assurance personnel. Work toward laboratory accreditation (ISO/IEC 17025.2005). Develop, update, or revise quality assurance manuals in needed lab sections. Develop documentation system for lab personnel competencies by trainings, qualifications, or certifications. The funds necessary to achieve these goals will be used to accomplish and dedicate infrastructure in order to strengthen the food protection mandate under the Food Safety Modernization Act. This integrated conformance will help develop and better direct state and federal activities using a risk-based approach model. State laboratory accreditation to ISO 17025 standards will assist in completion of Standard Ten of the MFRPS, thus positioning FDA ability to utilize analytical work done by state labs toward support of an integrated national food safety system.

Public health relevance
Georgia Department of Agriculture - Lab Accreditation Project Narrative Georgia will continue to strive toward full conformance with the MFRPS by building capacity in an integrated food safety program consisting of combined contributions from state, local, and federal collaborators. This project will focus on ensuring that equivalent quality assurance systems are in place at the primary chemical and microbiological servicing laboratories through non-partial, internationally recognized, accrediting bodies. This grant will be used to achieve, maintain, and enhance laboratory accreditation in the GDA laboratories to the ISO/IEC 17025.2005 standards.